Supplement to NIH Award 2 R35GM128562-06

ABSTRACT
Oxidative stress is a prevalent and dangerous cellular condition resulting in deleterious modifications to the
structure of DNA. These modifications promote mutagenesis and consequently the development of numerous
human maladies, including cancer. The base excision repair (BER) pathway is the cells primary defense
against oxidative DNA damage and is a vital guardian of genome stability. While the roles of individual
enzymes during a classical BER cycle are largely established, it remains enigmatic how these enzymes
function together in a multi-protein/DNA complex to facilitate the channeling of toxic DNA repair intermediates
between each protein. Importantly, BER not only occurs on naked duplex DNA, but also within chromatin that
is composed of nucleosomes. These nucleosomes present a barrier to BER enzymes accessing and
effectively repairing DNA damage. The mechanisms by which DNA repair proteins overcome this barrier to
repair DNA damage in the nucleosome is poorly understood. The major goals of this proposal are to
understand the molecular mechanisms of each BER factor both individually and within larger multi-
protein/DNA complexes using naked duplex DNA and chromatin; and to decipher the molecular mechanism
by which telomerase replicates the telomere. Elegant biophysical approaches are required to elucidate these
BER complexities and to provide both a foundation for interpreting the biological response and the
development of therapeutic treatments. We are in a unique position to advance this scientific front based on
my strong track record in DNA damage and repair, assembled team of collaborators, and multidisciplinary
approach. To meet this goal, we utilize a comprehensive approach of time- lapse X-ray crystallography,
molecular dynamic simulations, enzyme kinetics, single-molecule total internal reflection microscopy, and
cryo-EM. Using these methodologies, we will determine 1) how do new fundamental mechanistic steps alter
the DNA polymerase and telomerase mechanism; 2) how do individual BER enzymes assemble into a multi-
protein/DNA complex to facilitate the channeling of toxic DNA intermediates; 3) how are multi-protein/DNA
BER complexes structurally organized; 4) how is DNA damage identified and repaired within nucleosomes;
and 5) how are multi-protein/DNA BER complexes formed on nucleosomes containing DNA damage. This set
of questions will go from an atomic level mechanistic understanding of key BER components to the structural
and dynamic interactions within the entire BER multi-protein complex. By doing this, we will lay the foundation
to address an inherent challenge in establishing cellular models and developing new therapeutic treatments
that target DNA repair. With this information in hand, we will be closer to our long-term goal of providing a
basis for rational drug design towards the development of more effective chemotherapeutics and synergistic
drug combinations that target proteins involved in the DNA damage response.

Public health relevance
PROJECT NARRATIVE Project Narrative DNA damage arising from oxidative stress promotes multiple human diseases, and the primary cellular defense against this oxidative DNA damage is the multi-protein base excision repair (BER) pathway. The overarching goal of this proposal is to understand the molecular mechanisms of each BER factor both individually and within larger multi-protein/DNA complexes using naked duplex DNA and nucleosomes. We will employ elegant biophysical approaches to elucidate inherent BER complexities, while providing both a foundation for interpreting the biological response and the subsequent development of rational therapeutic treatments towards enhancing human health.